Investigating Nursing Home Emergency Preparedness for Environmental and Climatological Determinants of Resident Health

PROJECT SUMMARY
The medical and functional needs of nursing home residents impose a differential risk of morbidity and
mortality due to severe weather events, including hurricanes. A potential explanation for the increases
observed in adverse resident outcomes after hurricane exposure is inadequate compliance by nursing home
facilities to federal emergency preparedness standards; however, prior research has not rigorously evaluated
this association. Furthermore, nursing home characteristics, such as private versus not-for-profit or public
ownership, are known to affect resident outcomes, but the impact of ownership on emergency preparedness
and post-disaster outcomes is unknown. To address these knowledge gaps, we propose a retrospective cohort
study using data from the Centers for Medicare and Medicaid Services (CMS) and National Oceanic and
Atmospheric Institute (NOAA) to evaluate facility-level and resident outcomes as a function of exposure to
Hurricane Michael (2018) and administrative emergency preparedness. Within our analytic sample of 1,423
nursing homes, we have classified 317 nursing homes as exposed to Hurricane Michael. Evaluating the post-
disaster outcomes of 30-day all-cause mortality (primary), 30-day hospitalization, and 120-day functional
decline, we will use predictive modeling to identify which of the 250 federal emergency preparedness
deficiencies identified in CMS Life Safety Code inspections are most predictive of the facility-level rate of
adverse post-disaster outcomes (Aim 1). We hypothesize that deficiencies pertaining to evacuation and
sheltering preparedness will be included within this subset of “critical deficiencies.” In Aims 2 and 3, we will
construct a dichotomous measure of noncompliance from the subset of critical deficiencies identified in Aim 1
(i.e., a nursing home with ≥1 critical deficiencies will be classified as noncompliant). In Aim 2, we will evaluate
whether the impact of hurricane exposure on the resident-level likelihood of adverse post-disaster outcomes is
modified by noncompliance. We hypothesize that noncompliance will confer an increased risk of adverse post-
disaster resident outcomes. Lastly, we will assess whether private nursing home ownership is associated with
the resident-level likelihood of adverse post-disaster outcomes, and whether this potential association is
mediated by noncompliance (Aim 3). We hypothesize that residents from privately owned nursing homes will
have worse post-disaster outcomes, and that these associations will be mediated by noncompliance. Our
integration of geospatial data with administrative health and compliance data positions us to provide the first
empirical assessment of the relative importance of individual federal emergency preparedness standards and
the mechanisms by which they affect nursing home resident outcomes. The proposed research responds to
federal priorities regarding the need to improve emergency preparedness for an aging population, and will
identify modifiable factors that can be intervened upon by nursing home staff and regulators to improve
resident outcomes after exposure to severe weather events.

Public health relevance
NARRATIVE Identifying modifiable factors that can improve nursing home resident outcomes after exposure to severe weather events is relevant to both public health and to the emerging priorities of the National Institute on Aging. By linking administrative compliance and health data with geospatial data classifying exposure to Hurricane Michael, the proposed research will quantify the relative importance of federal emergency preparedness standards to nursing home resident outcomes and empirically evaluate mechanisms (effect modification and mediation) by which compliance with these standards could affect post-disaster resident outcomes. The findings from the proposed work will elucidate opportunities for regulators and nursing home staff to intervene upon the factors that render residents most susceptible to adverse outcomes after severe weather events.